Advanced Training in Nursing Outcomes Research

Project Summary
Advanced Training in Nursing Outcomes Research
This a competing continuation of Penn Nursing's T32NR007104 pre- and post-doctoral training program in
nursing outcomes research now in its 19th year. Ninety-two percent of T32 PhD alumni and 94% of
postdoctoral alumni are faculty at research-intensive institutions; 77% of PhDs and 79% of postdoctoral
trainees have competed successfully for research funding post training. Trainees were recruited from a robust
national pool of applicants and are now employed in 44 different institutions in 24 states. Over the life of the
T32, 34% of trainees have been minorities. Funding is requested for continuation of 5 pre-doctoral positions,
and a reduction of post-doctoral trainees from 4 to 3 to enable investments in more postdoctoral trainee
coursework in advanced quantitative methods. The T32 is embedded in the award-winning Center for Health
Outcomes and Policy Research (CHOPR) at Penn Nursing that provides trainees with exemplary resources
and learning opportunities. These include: 1) mentorship by prominent CHOPR nurse researchers who have 7
currently funded R01s in nursing outcomes research plus other funded large-scale studies; 2) CHOPR analytic
staff designated to support T32 training in computer applications for Big Data; 3) T32 nurse investigator
preceptors from Penn Nursing whose research is in the new emphasis topics of serious illness; 4) a large
interdisciplinary T32 faculty with relevant funded research and expertise in advanced quantitative methods;
and 5) access to a unique and robust Big Data inventory from CHOPR's NIH/AHRQ research, the Leonard
Davis Institute of Health Economics' health services research data repository, and the clinical data warehouse
of the large University of Pennsylvania Health System. The training emphasis continues to focus on areas of
research in which T32 faculty and trainees have made significant contributions to the advancement of
knowledge about the impact of nursing on patient outcomes exemplified by the T32 faculty's research
published in The Lancet and highlighted in the current NINR Strategic Plan. The T32 is enhancing the pipeline
of nurses into PhD study by recruiting BSN to PhD applicants and expediting PhD training to completion in 3
years, an objective that we have been successfully achieving. In this application, we specify new areas of
inquiry that extend the testing of our central thesis that the potentially modifiable organizational context of
nursing practice across settings of care and patient populations is significantly associated with care outcomes.
New directions include nursing's impact on clinical outcomes among seriously ill and high-need patients across
the lifespan and across settings. This focus reflects the priority set by the National Academy of Medicine's
report Effective Care for High-Need Patients that require a disproportionate share of nursing care. We heed the
call in the NIH Strategic Plan for Data Science to enhance research training by emphasizing data science and
Big Data approaches.

Public health relevance
Project Narrative This proposal is for continuation of the longstanding and successful program “Advanced Training in Nursing Outcomes Research” that produces expert nurse researchers in clinical patient outcomes research using advanced quantitative methods and data science approaches. Our 3-year program addresses the call to produce PhD-prepared nurse researchers in fewer years and at younger ages to make sustained contributions to nursing science, improved clinical care, and education of the next generation of nurses.